Outreach Core

Project Summary
Crucial to the long-lasting impact of the Center for Cancer Systems Therapeutics (CaST) is a robust and inclusive
Outreach effort. The community and computational infrastructure established by CaST Outreach in 2016-2022
will be leveraged as the foundation for the proposed core ForCaST (outreach For CaST) to meet the education
and outreach challenges put forth by the Cancer Systems Biology Consortium (CSBC). ForCaST will expand the
scope of CaST Outreach to 1) develop widely accessible containerized software environments with tutorials and
case studies for CaST tools; 2) forge new partnerships with cancer researchers and clinicians; 3) cultivate the
next generation of diversity-promoting scientists; 3) strengthen connections with students from groups that are
underrepresented in STEM disciplines; and 4) foster systems approaches in science more generally.
The overall mission of ForCaST will be realized synergistically through its Specific Aims: 1) WebCaST (Webbased CaST resources) for online containerized packages that will combine CaST publications and resources
with documented and video tutorials, domain-specific case studies, and computational workflows to facilitate
dissemination and adoption; 2) WebCaST-High (WebCaST for high school students) that will introduce highschool students from nine high schools in NYC, LA, and Detroit, to exploratory analysis of cancer data and
computational systems biology; 3) BroadCaST (Broadly accessible CaST research) for equipping students from
Brooklyn College for graduate training at Columbia and careers in biomedical sectors; 4) StudioCaST (Studio art
in CaST) for the creation of Visual Language at the intersection between Science and Art to offer novel learning
perspectives and to palpably translate experiences associated with a cancer diagnosis to researchers and
students; and 5) CaSTanet (CaST networks for inclusion) for mentoring postdoctoral scientists to provide
equitable opportunities in their future roles at academic institutions as faculty members, instructors, lab heads,
mentors, and reviewers.
ForCaST has already established key partnerships to support the proposed activities including 1) resource
sharing with the CSBC and broader Columbia communities such as the Columbia University Cancer Research
Career Enhancement Core (CRCE); 2) collaborations with Columbia University and Brooklyn College Continuing
Umbrella of Research Experiences (CURE); 3) partnerships with high schools through Columbia CURE and the
Palazzo-Strozzi Foundation; and 4) the creation of a new CSBC working group – Navigating Cancer with Science
and Art. Foundational to the success of ForCaST is a strategy of differentiated learning and formative
assessment that will ensure that CaST research products and the underlying concepts and skills required to
comprehend them, are shared through a variety of vehicles in order to maximize appeal to scientists, clinicians,
and students.